Reliable prediction of high-risk infants of autism with cortical microstructural biomarker

Abstract
The diagnosis of neuropsychiatric disorders such as autism spectrum disorder (ASD) is based on
behavioral assessments that cannot be confirmed until 2-3 years of age. ASD affects 1 in 59 children in the
U.S., and infants from high-risk families have 20 times of risk to develop ASD compared to the general
population. Current paradigm misses the precious time window for potential early intervention from birth to 2-3
years of age. Therefore, the focus in ASD research is shifting toward developing early biomarkers which can
predict the risk of an infant developing future behavioral abnormalities, while the infant is still in pre-
symptomatic stage. Imaging markers play major roles in understanding of both ASD and typical developing
(TD) brains. Neural MRI at early infancy may improve the current paradigm for diagnosis for ASD in high-risk
infants. Macrostructural measurements such as cortical thickness and surface area from conventional T1
weighted MRI (T1w) have been the primary measurements for characterizing the maturation of infant cortex.
However, T1w MRI cannot reveal information about the complex microstructural changes inside the cortical
mantle. Cortical microstructure, associated with the underlying cellular and molecular processes, plays a vital
role in neuronal circuit formation and emergence of brain functions. We have recently developed a novel
protocol to quantify the cortical microstructure using advanced diffusion MRI (dMRI), including diffusion tensor
imaging (DTI) and diffusion kurtosis imaging (DKI). These advanced dMRI-based cortical microstructural
measurements are sensitive imaging markers for the microstructural differentiation that characterizes the infant
cortex maturation. We hypothesize that dMRI-based cortical microstructure measurements in early infancy
could be potential biomarkers for early detection of ASD in high-risk infants. The goal of this study is to develop
and test a novel protocol, using dMRI-based cortical microstructure feature, to reliably predict clinical score of
infants at high risk for ASD and other brain disorders in general. We aim: 1) to develop a technique that
incorporates dMRI-based cortical microstructural measures at early infancy with cutting-edge multi-kernel
machine learning algorithms to reliably predict infants’ future neurodevelopmental outcomes at 2 years of age;
2) to demonstrate the initial clinical utility of the technique in infants at high-risk for ASD. To accomplish these
goals, we leverage a large cohort of infant study that consists 100 TD infants who longitudinally undergo multi-
modal MRI scans at early infancy and neuropsychological testing at 2 years for developing the prediction
techniques, and a high-risk ASD study that allows us to longitudinally image the infants during infancy for
testing our developed techniques. Finally, it should be emphasized that, although the present project focuses
on its clinical applications in infants at high risk for ASD, the method developed also has important utility in
detecting behavioral abnormalities in high risk subjects for other brain disorders (e.g. schizophrenia, ADHD), at
a time prior to the age of diagnosis. Thus, this technique is expected to have a broad clinical impact.

Public health relevance
Narrative Diffusion magnetic resonance imaging (dMRI) based cortical microstructural measurements are sensitive markers characterizing infant cortex maturation. The present application aims to develop a technique that incorporates these advanced dMRI-based cortical microstructural measures at early infancy with cutting-edge machine learning algorithms to reliably predict infants’ future neurodevelopmental outcomes and clinical scores. This technique is expected to have a range of clinical applications in detecting behavioral abnormality in subjects at high risk for neurodevelopmental disorders, at a time prior to the age of diagnosis.